Novel regulation and functions of TEAD-VGLL complex

Abstract
TEAD transcription factors bind to the transcription co-activators YAP/TAZ, and control the
transcriptional output of the Hippo pathway. In addition, TEADs could bind to Vestigial-like
family proteins (VGLL1-4), regulating distinct transcription programs. Among all VGLL family
proteins, VGLL3 has been shown to play critical roles in development, immune regulation and
tumorigenesis. However, the detailed mechanisms and functions of TEAD-VGLL complex
remains unclear. Here we identified TEAD binds to VGLL with distinct structural features, and
alternative activation of TEAD-VGLL3 complex confers resistance to TEAD inhibitors (TEADi).
We identified a new class of TEAD inhibitors, which could effectively block TEAD-VGLL3
complex, offering new structural and pharmacological insights to target TEAD-VGLL3 in
signaling and diseases.
Our specific aims of this proposal include: (1) To characterize the structure and functions of
TEAD-Vgll3 complex. (2) To investigate the functions of TEAD-Vgll3 in TEADi resistance (3) To
develop new generation of TEAD inhibitors blocking TEAD-Vgll3 complex.

Public health relevance
Project Narrative TEA domain family (TEAD/TEF) transcription factors bind to YAP/TAZ to regulate Hippo pathway transcriptional output. In addition, TEADs bind to VGLL family of protein to regulate distinct transcription programs which play critical roles in regeneration, inflammation and development. However, the detailed regulation and functions of TEAD- VGLL complex are unclear, and our proposed structural and mechanistic studies will provide new insights into TEAD-VGLL complex in the development of multiple diseases.